Mechanism of Colonization Resistance

PROJECT SUMMARY
Antibiotic treatment impairs colonization resistance, thereby increasing the risk of infection with
Enterobacteriaceae that are frank (e.g. non-typhoidal Salmonella serovars) or opportunistic (e.g.
carbapenem-resistant Enterobacteriaceae) pathogens. However, how the host contributes to
colonization resistance against pathogenic Enterobacteriaceae remains incompletely understood.
The host uses “habitat filters” to select for microbial traits permitting survival and growth in the
host, thereby shaping composition, spatial organization and size of microbial communities. Our
goal is to elucidate how the host contributes to colonization resistance against pathogenic
Enterobacteriaceae and to develop approaches aimed at restoring this nonspecific immune
function during antibiotic therapy. We hypothesize that a mechanistic understanding of how the
host contributes to colonization resistance against pathogenic Enterobacteriaceae will facilitate
the development of drugs that target host signaling pathways to strengthen colonization
resistance. We will test different aspects of our hypothesis in two specific aims. Specific Aim 1
will identify resources that a shift in epithelial metabolism provides for pathogenic
Enterobacteriaceae to overcome niche modification by microbiota-derived short-chain fatty acids.
Specific Aim 2 will provide a proof-of-principle for the idea drugs targeting the host can strengthen
colonization resistance, thus making it possible to preserve this nonspecific immune function
during active antibiotic therapy. Successful completion of the proposed work will provide
mechanistic insights into a key function of the microbiome, which will be of wide appeal among
researchers interested in microbial pathogenesis, microbiota research, and intestinal biology.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Over 90% of the cells in the human body are microbes, the majority of which reside in the large intestine, where they provide benefit to the host by providing niche protection against colonization with potentially harmful bacteria, a property known as colonization resistance. Antibiotic therapy is accompanied by a microbial imbalance that leads to a loss of colonization resistance. Here we will study the underlying mechanism by which antibiotic treatment increases susceptibility to potentially harmful bacteria and approaches to restore colonization resistance, which will usher in important conceptual advances that have a strong potential to exert a high impact on this field of science.